Cellular senescence and Associated Lysosomal Dysfunction in Immune Aging

PROJECT SUMMARY/ABSTRACT
Cellular senescence is an age-related process, affecting cells that have either divided too much or
suffered significant damage to their DNA, which involves both a halt to further proliferation and the elaboration
of a secretory program that activates the immune system, presumably to flag these cells for immune clearance.
Although this is likely an important mechanism to prevent cancer, it is also a two-edged sword. Growing
evidence indicates that the accumulation of uncleared senescent cells drives a steady, age-dependent
increase in basal inflammation, termed “inflammaging”, that causes cumulative damage in many tissues,
contributing to their age-related degeneration. Importantly, senescent cells can induce new senescence in
adjacent normal cells via their secreted factors, suggesting that the accumulation of senescent cells is a self-
amplifying, exponential process. The role of the immune system in this vicious cycle is complex and particularly
important, as based on available evidence it both mediates the inflammation-related destruction and may
contribute to the vicious cycle via senescence within the immune system itself.
T cells in the human immune system can be very long-lived, and have the ability to infiltrate almost any
tissue and cause destruction in various ways, but the role of senescence within the T cell repertoire is still
poorly understood. Several recently developed flow cytometry-based assays can readily measure in blood-
derived immune cells the lysosomal dysfunction known to be strongly associated with cellular senescence in
other cell types, but it is not yet clear if that means these cells are truly senescent. Nonetheless, such
lysosomal stress may still be indicative of potentially destructive cellular phenotypes, based on our own
preliminary data and other published studies. This matters because the lysosomal dysfunction, if it is causative
of these destructive properties, can be targeted by a variety of available interventions that may provide benefit
regardless of whether or not the pathogenic cells affected are canonically senescent. Conversely, if the cells in
question are truly senescent, other classes of drugs (i.e. senolytics, senomorphics) may induce their clearance
or reverse their pathogenicity. Understanding how these cellular phenotypes arise in the T cell repertoire, how
they can be detected in blood samples, and how they may be related to immune dysfunction in older
individuals, is therefore an important undertaking for public health. This proposal seeks to advance these aims
by bringing to bear a suite of state-of-the-art flow cytometry, proteomic, and gene expression profiling-based
techniques, combined with functional readouts, to definitively identify which lysosomally stressed T cells may
have pathogenic potential, and to map their occurrence across a cohort of 120 young and old donors of both
sexes. This work when completed will have generated a number of new diagnostic tools to detect specific
aging-related populations of T cells with potentially harmful properties, as well as having developed some early
preclinical leads as to what classes of drugs may clear them or mitigate their pathogenicity.

Public health relevance
PROJECT NARRATIVE The purpose of the work proposed here is to better understand how age-dependent dysfunction in human T cells, in terms of both their ability to amplify inflammation and defects in their effector function against pathogens, might result from cellular senescence, the often but not always senescence-related dysfunction of their lysosomal compartment, or both. Clarifying these questions will benefit public health by potentially identifying novel strategies for the targeting of these pathways in T cells for the improvement of both general health and immune function in aged individuals.